Investigation of the effects of CXCR1/2 inhibition on the immune microenvironment of patients with multiple myeloma

Summary
Multiple Myeloma (MM) is the second most common hematologic malignancy and is considered incurable for
most patients. There has been significant improvement in MM patient survival, mainly due to the use of novel
treatments including immunomodulatory drugs (IMiDs), proteasome inhibitors (PIs), monoclonal antibodies
(mabs), bispecific antibodies and cellular therapies. However, many of these treatments heavily rely on a healthy
patient immune system to fully leverage their efficacy. Unfortunately, prior studies have shown that the
phenotype and function of immune cells in the BM tumor microenvironment (TME) in MM is dysregulated. The
accumulation of pathological myeloid cells has emerged as a major mechanism by which tumors evade anti-
tumor immunity and are a primary obstacle to develop efficient cancer immunotherapies. To characterize the
phenotype and transcriptional changes in myeloid cells in tumor, we used single-cell transcriptomics to dissect
the differences between the myeloid cell populations in the BM and osteolytic lesions (OL) TME of MM patients
(N = 13) and compared them with myeloid ME of BM of healthy controls (HDBM) (N = 3). OL are an aggressive
manifestation of MM and can lead to pathologic fractures. We discovered a significant accumulation of CXCR2
positive myeloid cells in BM and OL of MM patients but not HDBM. Using murine preclinical models of MM, we
found that targeting CXCR2 positive cells using anti-CXCR2 drugs alone or in combination with standard
treatment (bortezomib plus dexamethasone) significantly increased the overall survival in tumor bearing mice.
CXCR2 inhibitors are safe, effective, and commercially available (the CXCR1/CXCR2 inhibitor (SX-682) used in
this trial is provided by Syntrix Pharmaceuticals). The goal of the clinical trial from which the samples for this
correlative study are obtained is to explore safety and tolerability of CXCR2 blockade as a novel, yet practical
approach that effectively mitigates myeloid cell dysregulation in MM patients to boost the response to standard
treatments in a phase I clinical trial with two specific aims: Aim1) Evaluate the effect of SX-682 on the spatial
architecture of the TME in MM on bone marrow samples at baseline and after 6 cycles of treatment. Aim 2)
Evaluate the immunomodulatory effect of SX-682 on the BM TME and peripheral blood (PB).

Public health relevance
Multiple Myeloma (MM) is the second most common hematologic malignancy and remains largely incurable despite advancements with novel treatments like immunomodulatory drugs, proteasome inhibitors, monoclonal antibodies and cellular therapies. The efficacy of most of these treatments relies on a healthy immune system, but MM disrupts immune cell function in the bone marrow, with pathological myeloid cells aiding tumor evasion. The goal of this study is to evaluate the immune response in bone marrow and peripheral blood in samples obtained from patients enrolled in a phase I clinical trial aiming to test the safety and efficacy of the CXCR2 inhibitor SX-682, which targets these myeloid cells, in combination with standard treatments to improve patient outcomes.